The Taxi Network

DESCRIPTION (provided by applicant): There are over 230,000 taxi drivers in the U.S. and 42,000 in New York City (NYC), where 84% are immigrant. Taxi drivers are at great risk for poor health, with increased cardiovascular disease (CVD) and overlapping cancer risk, due to stress, diet, sedentary lifestyle, environmental exposures, and poor health care access. The taxi driver community, while facing tremendous health risk, also has notable assets to facilitate the health of its drivers. Community networks have the potential to disseminate health risk reduction information and strategies. The overall goal of this Taxi Network proposal is to create a robust community- based participatory research (CBPR) infrastructure that taps into the many assets of the taxi driver community, to work towards the elimination of health disparities in this large a-risk group. The specific aims include: 1. To develop a robust, enduring, fluid CBPR program with the large NYC taxi driver community, co- led by community and scientific research partners, with an active Taxi CAB (Community Advisory/Action Board), and Advisory and Steering Committees, to create a platform for co-learning, sharing resources and dissemination of outreach, education, service delivery, research, and policy action projects, to improve the cardiovascular health of this large at-risk community. 2. To work with the Taxi CAB to use a mixed methods approach of focus groups, key informant interviews, questionnaires, social network analysis, and resource mapping to conduct a detailed analysis of the health-related priorities, needs and assets of the taxi driver community, and the potential points and methods of intervention. 3.To design and pilot a CBPR CVD risk reduction pedometer exercise study, tailored to reflect the unique circumstances of the taxi driver community and capitalizing on assets such as their social networks and the window of opportunity of the airport holding lot. Taxi Network has been developed through an ongoing, iterative process with the community, and builds upon extensive preliminary work in this area. RELEVANCE (See instructions): This Taxi Network CBPR program has the potential to significantly change the paradigm of health care delivery and cardiovascular disease prevention activities for the large, growing at-risk taxi driver population in NYC, across the nation, and globally.